Biobehavioral mechanisms underlying symptoms and healing outcomes in older individuals with CVLU

ABSTRACT
Our long-term goal is to elucidate the complex biobehavioral mechanisms responsible for symptoms and
healing outcomes for older adults’ with venous leg ulcers (VLUs) for the development of targeted therapies that
address both the patient-oriented outcomes and healing outcomes in this growing group of affected individuals.
VLUs, which account for 70–90% of ulcers found in the lower leg, affect 2 million persons annually, including
nearly 4% of people over age 65 years. To date, the basic biology underlying the development and persistence
of VLUs and the influence of aging and multiple disease conditions on wound healing are generally not well
understood. Individuals living with chronic VLU (CVLU) have a high symptom burden of both wound-related
symptoms and symptoms of pain, depression, anxiety, fatigue and cognitive dysfunction, collectively labeled as
“psychoneurologic symptoms (PNS).” Guided by the National Institutes of Health Symptom Science Model
(NIH-SSM) framework, the central hypothesis of this application is that there are interrelated molecular
mechanisms by which the immune activation that contributes to the development and persistence of CVLU
also leads to the development, persistence and severity of PNS. The specific aims of the proposed study are
to: (1) Characterize the strength of the associations at baseline among patient-host factors, systemic
inflammation, and wound microenvironment with wound area and symptoms (PNS and wound-related); and,
(2) Test associations and models over time for: (a) Patient-host factors and systemic inflammation with wound
microenvironment; (b) Patient-host factors and wound microenvironment with systemic inflammation; (c)
Patient-host factors, systemic inflammation, and wound microenvironment with wound healing; (d) Patient-host
factors, systemic inflammation, and wound microenvironment with symptoms (PNS and wound-related) and (e)
Patient-host factors, systemic inflammation, wound microenvironment and wound healing with symptoms (PNS
and wound-related). To achieve the specific aims, we will longitudinally examine 200 older adults (age >60)
who are receiving state of the art, standardized wound treatment biweekly across eight weeks time. We will
fully characterize patient-host characteristics (age, comorbidities, sex, race/ethnicity, BMI, nutritional status,
lifestyle habits, and wound treatment [pressure therapy, debridement, antibiotics]); systemic inflammatory
activation (C-reactive protein and cytokines); wound microenvironment factors (local inflammation [Matrix
metalloproteinase (MMP) enzymes C-reactive protein, cytokines], biofilm, and micro RNAs); symptoms (PNS
[cognitive dysfunction, pain, fatigue, and depressive/anxiety symptoms] and wound-related); and wound
characteristics and healing trajectory at the five timepoints. This knowledge is critical to provide a foundation
for developing targeted interventions to address this critical health problem from a holistic perspective and to
provide a basis for preventing or reversing the adverse health outcomes of CVLUs, a condition that
differentially affects older and minority individuals.

Public health relevance
Public Health Relevance Chronic non-healing wounds (CNHW) are a significant public health burden estimated to affect over 6 million people in the United States; indeed, national healthcare expenditures associated with CNHW exceed $20 billion annually and continue to rise due to increasing prevalence and a rapidly aging population. Venous leg ulcers, which account for 70–90% of ulcers found in the lower leg and affect between 500,000 and 2 million persons annually, are a particularly challenging type of CNHW due to their association with multiple morbidities and high rates of non-healing. Older persons (age 60 and over) with CVLUs are a vulnerable population due to an increased incidence of infection, prolonged healing, and pain and discomfort, which are associated with immobility and poor quality of life. This program of research aims to enhance the health outcomes of older individuals with chronic non-healing wounds by elucidating the complex biobehavioral factors that influence the trajectory of healing and patient-oriented symptoms, including distressing pain, fatigue, and depression.